Development of multimode vacuum ionization for use in medical diagnostics

There is a critical need for rapid and cost-effective means for the detection of e.g. infectious diseases at an early stage, drug
overdoses, and other health related testing necessities. Thus, significant commercial opportunities exist because of the lack
of these capabilities as painfully “demonstrated” in the current pandemic. Mass spectrometry (MS), because of its ability to
detect hundreds, even thousands, of biological compounds in a single acquisition provides the capability to distinguish
chemical differences associated with, e.g., different pathogens and disease states, as well as target specific compounds in
bodily fluids. Current MS approaches use ionization methods requiring user expertise and frequently specialized
instrumentation, which significantly increases cost. Over the past 30 years, mass spectrometers have undergone a
renaissance in their cost-to-capability ratio. For more widespread applications of MS in advancing healthcare, there is a
need for new advanced ion source technology that provides for minimal user intervention and long-term use without
maintenance. These attributes are necessary if testing of thousands of individuals daily per instrument to e.g., identify, track,
and contain the spread of infectious diseases is to be implemented using MS in the future. The goal of this NIH SBIR Phase
I project is to demonstrate that an entirely new ion source concept constitutes a disruptive technology and effective method
that can be used for the next-generation disease test measurements. The basic invention of this proposal is covered by a
MSTM patent application (#20210343518, March 31, 2021), and earlier IP exclusively licensed to MSTM which can be
applied to widely available atmospheric pressure ionization mass spectrometers, including portable and ultra-high
performance. Critical advantages include exceptional ease of use, robustness to instrument contamination and carryover,
high-throughput, low cost, and the capability to retrofit with most commercial mass spectrometers to provide rapid,
sensitive, and accurate data on demand. The objective of this Phase I project is to demonstrate the feasibility of this
technology by constructing a manual dual vacuum ionization source that can be automated in Phase II for nearly hands-free
operation and disease identification through machine learning algorithms. The specific aims towards establishing a
potentially disruptive healthcare technology: Aim 1: Construct a manual vMAI/MALDI source capable of future automation
(minimal viable product). Aim 2: Demonstrate high sensitivity, reproducibility, robustness, speed of analysis, as well as
ease of use, quantification, accurate mass, MS/MS, and fingerprint analyses of pathogens. MSTM has the necessary
expertise and facilities to bring this Phase I project to a successful conclusion within 9 months. Our strategy is to collaborate
with one or more equipment manufacturer which is necessary to effectively expand into the healthcare market (letters
Bruker, Medtronic, Thermo, Waters).

Public health relevance
Project Narrative The critical need for early and rapid testing with nearly instantaneous and highly accurate results in the event of a rapidly spreading and previously unknown infectious agent was made clear by Covid-19, where many lives could be saved or improved by earlier disease detection. Developing, manufacturing, and widely distributing specific tests is slow and often with undesirable false positive/negative results, thus providing significant commercial opportunities for mass spectrometry (MS) instrumentation capable of detecting in a single acquisition a wide variety of infectious agents, diseases, poisons, etc. MSTM, LLC is developing a revolutionary MS-based product to meet this challenge by 2025 with the potential to significantly lower cost through simpler, more robust, and user-friendly high-throughput technology in combination with artificial intelligence programs.